CLINICAL SITE AND STUDY MONITORING FOR RESEARCH PARTNERSHIPS FOR GLOBAL MENTAL HEALTH.

The Contractor shall provide comprehensive clinical site and study monitoring services for the NIMH/Center for Global Mental Health Research (ORDGMH)CHIRMH clinical trials.